Human Mitochondrial Variation and Sudden Cardiac Arrest Risk and Resuscitation

Sudden cardiac arrest (SCA) is a major public health concern, accounting for up to 400,000 deaths each year.
While SCA cases are heterogeneous in etiology, the most common underlying pathologic substrate is ischemic
heart disease and the most common electrophysiologic mechanism is ventricular fibrillation (VF). Survival
following VF-SCA is less than 20% in most communities with mortality due largely to fulminant injury of either
the heart or brain. Accordingly, there is a compelling case to identify novel modifiable SCA risk factors, to
elucidate its underlying pathophysiology, and to identify novel preventative and therapeutic targets. The
mitochondrion has primary function in energetics, oxidative stress, and apoptosis, and serves as both a target
and an effector of ischemia-reperfusion injury. Consequently, mitochondria have a fundamental role in
arrhythmia risk and in cardiac and brain resuscitation. Indeed, we have previously demonstrated that
mitochondrial DNA (mtDNA) copy number (-CN), which reflects the number of MT genomes per cell, is a novel
risk factor for SCA, independent of traditional SCA risk factors. MtDNA-CN, however, captures the quantity of
mitochondria. It does not capture their quality. We have recently identified a series of mtDNA haplotypes that
capture functional genetic variation, and developed a computational tool to accurately assess somatic mutations
in mitochondria (heteroplasmy), allowing for a comprehensive survey of mtDNA genetic variation. Thus, we
propose to test the hypothesis that mtDNA variation (mtDNA-CN, inherited mtDNA haplotypes and rare
mutations, mtDNA heteroplasmy [somatic variants]) will be associated with SCA risk and resuscitation outcomes.
We will examine the association of SCA with mtDNA characteristics in 2,600 SCA cases from a large population-
based case-control study of SCA and validate our findings in two population-based cohort studies where SCA
cases have been identified prospectively and two case-control studies of autopsy confirmed SCA subjects. We
will also examine the association of mtDNA variation with cardiac resuscitation (restoration of sustained
circulation) and brain recovery among 2,600 VF-SCA cases followed prospectively. Second, we will characterize
the consequences of specific mtDNA variation on mitochondrial function and cardiomyocyte (CM) electrical
activity. We will assess the impact of mtDNA variants associated with known rare diseases with CM involvement
across a range of heteroplasmies using human induced pluripotent stem cell CMs (hiPSC-CMs) to directly test
whether deleterious heteroplasmic variants modify electrical excitability, repolarization or conduction, or
compromise the development or maturation of CMs. We will also leverage existing mtDNA base editing
technologies to assess the impact of variants associated with SCA risk and/or resuscitation outcomes. Together,
these aims will determine whether mtDNA genetic variation are associated with SCA risk and resuscitation and
will characterize the consequences of mtDNA variation on CM electrical activity. These investigations will lead
to innovative approaches to prevent SCA and improve VF-SCA resuscitation outcomes.

Public health relevance
Mitochondria play a key role in sudden cardiac arrest (SCA) risk and recovery. We will leverage data from a total of ~5000 SCA cases to identify, validate, and functionally characterize mitochondrial genetic variants associated with SCA risk and resuscitation outcomes. These investigations ultimately will lead to innovative approaches to prevent SCA and improve resuscitation outcomes.